The Mechanism and Regulation of the Dynein Transport Machinery

Project Summary
Cytoplasmic dynein is an AAA+ motor responsible for nearly all minus-end-directed motility and force generation
functions along microtubules (MTs). Surprisingly, a single dynein-1 heavy chain gene is responsible for an
enormous breadth of cellular activities in intracellular transport, MT organization, and mitosis, in comparison to
more than 40 plus-end-directed kinesin motors performing complementary functions on MTs. Dyneins were the
least studied of the cytoskeletal motors due to challenges in the reconstitution of active dynein complexes in vitro
and the scarcity of high-resolution methods for their in-depth structural and biophysical characterization. These
challenges have been recently addressed, and there have been major advances in our understanding of the
activation, mechanism, and regulation of dyneins. For example, we recently showed that the mammalian dynein
complex is a robust motor that rapidly walks along MT tracks and produces forces comparable to kinesins. We
also developed a robust mechanistic model for the activation of the dynein transport machinery by accessory
proteins, Lis1 and Nde1.
Our future goals are to dissect the mechanism of active dynein complexes and determine how dynein activation
and motility are regulated across multiple scales using biochemical reconstitution, single-molecule imaging, and
cryo-electron microscopy (cryo-EM). Specifically, we will use the recently developed MINFLUX method, single-
molecule FRET (smFRET), and protein engineering approaches to directly monitor the conformational dynamics
of the dynein motor domain during stepping. These experiments will fill critical gaps in our understanding of how
dynein couples ATP hydrolysis to a mechanical step at unprecedented resolution. We will also investigate the
mechanism of Lis1/Nde1-mediated activation of the dynein transport machinery using cryo-EM, smFRET, and
mutagenesis studies. These studies will reveal how Nde1 recruits Lis1 to autoinhibited dynein and facilitates the
opening of dynein for its assembly into functional transport complexes.
A large body of evidence shows that dynein is recruited to intracellular cargos side-by-side with kinesins through
cargo adaptors. These adaptors may also coordinate motor activity to avoid tug-of-war between the antagonistic
motors and determine which direction the cargo moves on MTs. To investigate the mechanism of motor
recruitment and coordination on a cargo, we will reconstitute the machinery that transports mitochondria
(Miro/TRAK/dynein/dynactin/kinesin) and autophagosomes (HAP1/Huntingtin/dynein/dynactin/kinesin) from
purified components. We will also investigate the assembly and regulation of dynein/dynactin by the NuMA
adaptor for its mitotic functions. We will characterize the assembly and motility of these complexes in vitro, and
use cryo-EM to gain structural insight into the coordination of motor activity on cargo adaptors.
The success of our research program will reveal the fundamental mechanochemistry of dynein and how it
achieves retrograde transport of intracellular cargos and performs specific functions in mitosis.

Public health relevance
Project Narrative Consistent with its fundamental roles in neurobiology and cell development, complete knockouts of dynein stop the entire MT transport machinery and inhibit mitosis. Mutations that alter dynein motility or the expression of dynein-associated factors lead to the pathogenesis of motor neuron degeneration, ALS, lissencephaly, and schizophrenia. A detailed investigation of dynein's mechanochemical cycle and its regulation by Lis1/Nde1 and cargo adaptor proteins will significantly contribute to our understanding of how defects in the assembly and activation of the dynein transport machinery contribute to human disease and provide insight into the development of specific chemical inhibitors of dynein function for the treatment of dyneinopathies.